Mapping Dynamic Changes in Protein Interactome using Proximity Labeling with High Temporal Resolution

PROJECT SUMMARY
Physiological and oncogenic signals are propagated through a chain of protein interactions. The assembly and
disassembly of key signaling complexes are often transient and can occur within minutes or even seconds.
Mapping dynamic changes in protein interactions is one of the main approaches for deciphering the regulation
of critical biological processes and for the identification of potential therapeutic targets in the treatment of
cancer. However, the interrogation of rapid changes in protein interactomes remains a significant challenge
due to the poor sensitivity and/or insufficient temporal resolution of current tools. We propose to develop a set
of tools that will enable the facile analysis of changes in protein interactions occurring within one minute or less
and will significantly improve the sensitivity of existing approaches. Currently, the most comprehensive
characterization of protein interactomes is achieved through the application of the biotin proximity labeling
approach. This method uses promiscuous biotin ligases, such as BioID or TurboID, that can biotinylate any
protein within a 10Å radius. By attaching a biotin ligase to a protein of interest, researchers can detect even
weakly associated protein complexes in living cells. However, detection of dynamic changes in the protein
interactome using this strategy has been challenging due to a poor signal-to-noise ratio when cells are labeled
with biotin for short periods of time (1-2 minutes). We will develop three orthogonal methods that dramatically
reduce the background signal during biotinylation and enable fast labeling of samples within one minute or
less. One approach will employ a light-regulated biotin ligase that demonstrates no activity in the dark, thus
minimizing the background biotin signal to the lowest level. Two other strategies will employ engineered biotin
ligases capable of labeling proteins with biotin analogs, desthiobiotin and iminobiotin. These two analogs offer
a significant advantage because they can be separated from biotin by affinity chromatography using selective
elution condition. This will allow us to reduce the background signal caused by endogenous biotin present in
mammalian cells and thus significantly improve signal-to-noise ratio. Furthermore, since all three technologies
utilize different biotin analogs, we can apply three different labels within the same cell and separate them
during the sample preparation. The application of this novel strategy will enable the labeling of different time
points in the same biological sample or the analysis of interactions for three different proteins within the same
cells. Overall, the combined advantages of the proposed tools will significantly enhance our capabilities for
dissecting the signaling processes driving tumor formation and progression.

Public health relevance
PROJECT NARRATIVE Signals driving cancer propagate through quickly changing protein interactions. Identification of these fast changes in protein interactions is critical for our understanding of processes driving tumor formation and development of novel therapeutic strategies. Here, we propose development of novel tools that will significantly improve our capability to characterize dynamic changes in protein interactions and decipher signals mediating oncogenic processes.